Community Engagement Core

CORE SUMMARY – COMMUNITY ENGAGEMENT CORE
The mission of the Oregon State University Superfund Research Program (SRP) is to identify polycyclic
aromatic hydrocarbons (PAHs) in the environment, characterize their toxicity, and specify the environmental
concentration below which they pose no threat to human health. The Community Engagement Core (CEC) will
help the Center achieve this goal by responding to the concerns of communities impacted by hazardous
substances and identifying effective public health intervention and prevention strategies that reduce the
amount and toxicity of PAHs and other harmful substances. Specifically, we will partner with the Swinomish
Indian Tribal Community, the Confederated Tribes of the Umatilla Indian Reservation, the U.S. Army Corps of
Engineers Pine Meadow Campground, and citizens who live adjacent to the Portland Harbor Superfund Site.
By leveraging resources of the SRP and our partners, the CEC will 1) identify and prioritize Tribal
environmental research questions and concerns, 2) identify and evaluate strategies that promote public health
and reduce the amount and toxicity of PAHs and other hazardous substances in food and the environment, 3)
evaluate how personalized chemical exposure data collected by a novel silicone wristband affects individual and
community-level awareness of pollution prevention strategies. By engaging participating in community-based
participatory research practices, the CEC will also foster trust, shared knowledge, scientific capacity, and
cultural competency among our partners and the SRP. Collectively, these efforts will advance knowledge of how
individuals in diverse communities can promote public health by preventing exposure to hazardous substances
found in their homes, their community, and/or their environment.

Public health relevance
CORE NARRATIVE – COMMUNITY ENGAGEMENT CORE The Community Engagement Core (CEC) will respond to the concerns of communities impacted by hazardous substances and identifying effective public health intervention and prevention strategies that reduce the amount and toxicity of PAHs and other harmful substances. We will partner with the Swinomish Indian Tribal Community, the Confederated Tribes of the Umatilla Indian Reservation, the U.S. Army Corps of Engineers Pine Meadow Campground, and citizens who live adjacent to the Portland Harbor Superfund Site. Our primary objective is to identify and evaluate strategies that promote public health and reduce the amount and toxicity of PAHs and other hazardous substances in diverse communities.